Studying stimulation of long-range cortical projections involved in visual-spatial behavior in non-human primates with a novel multimodal optoelectronic device

Irreversible blindness affects over one million people nationally and over 40 million globally, with most cases of
acquired blindness leaving the visual cortex intact. A cortical visual prosthesis (CVP) is a promising therapeutic
strategy for these individuals. However, the production of perceived visual sensations through stimulation of
long-range cortico-cortical connections has proven to be variable and inconsistent. There is a lack in
understanding of the biophysical mechanisms of cortical stimulation and its effects on neural dynamics and
behavior. Investigating these mechanisms has been limited by the model system and the neuro-technologies
available to interrogate that system. Projections from the posterior parietal cortex (PPC) to the prefrontal cortex
(PFC) in non-human primates (NHPs) are involved with saccades in visual-spatial attention and provide an
ideal and generalizable system to study long-range cortical dynamics during behavior. Retrograde adeno-
associated viruses (retroAAVs) can specifically target PPC-PFC projection neurons for optogenetic stimulation.
In Aim 1, a multimodal optoelectronic device with microLED and transparent microelectrodes will be developed
to enable colocalized optogenetic stimulation and electrical recording of the projection neurons with high
spatiotemporal resolution. In Aim 2, the retroAAV injection protocol will be optimized to achieve the highest
transduction efficacy. In Aim 3, the optoelectronic device and retroAAV strategy will be implemented to
introduce microstimulation of the PPC-PFC neurons in NHPs during a visual-spatial task. Our preliminary data
on successful optoelectronic device development, retroAAV expression, and optogenetic stimulation and
single-unit recording of PPC-PFC projection neurons reduce risk and validate feasibility for our proposal. The
results will improve our understanding of the biophysical mechanisms of how stimulation affects multiregional
cortical dynamics and visual behavior, informing the future development of effective CVPs.

Public health relevance
Over one million people in the US suffer from irreversible blindness, and cortical visual prostheses provide a promising therapeutic strategy, but the generation of visual percepts has remained variable and inconsistent. In this proposal, we seek to optimize optoelectronic and viral vector tools for optogenetics in non-human primates that will enable probing of long-range cortical projections during behavior. The results will improve our mechanistic understanding of how stimulation affects multiregional cortical dynamics and ultimately behavior, informing the future development of effective cortical visual prostheses and advancing the field toward clinical translation.